Molecular MRI of Brain Metabolism Enabled by Long-Lived Spin States

Molecular MRI of Brain Metabolism enabled by Long-Lived Spin States Abstract: Brain function is regulated by molecular signaling and metabolism, however our ability to track metabolic transformations of individual metabolites deep in the brain pales compared to their central relevance to life. It is our goal to establish technology for tomographic mapping of metabolites and their metabolic pathways directly in the brain. Specifically, we aim to map metabolic turnover of13C2-pyruvate, ethyl-13C2-pyruvate, 13C2-Vitamin C, 15N-Vitamin B3, 15N3-Metronidazole (a well-tolerated antibiotic and potential hypoxia probe), and 13C2-Acetate. All of these markers play critical roles in brain metabolism: pyruvate is a key entry point to energy metabolism and the tricarboxylic acid (TCA) cycle; Vitamin C (ascorbate) is a vital antioxidant molecule in the brain; Vitamin B3 (Nicotinamide) is a precursor to NAD (nicotinamide adenine dinucleotide), a key regulator of cellular and organismal homeostasis and redox-status; metronidazole is an antibiotic that undergoes quick turnover in hypoxic tissue and promises to be a very sensitive hypoxia sensor; Finally, acetate acts as an alternative energy source for the brain and exhibits rapid and differential uptake and metabolism in, for example, glioblastoma multiform, a deadly brain cancer. From a technological perspective, each of the proposed molecules can carry long-lived hyperpolarization in NMR-silent, yet RF-accessible quantum states. This property is important because it allows for very long-lived MRI signals from these molecules that can directly report on chemical transformations via changes in chemical shift and the scalar coupling network. This ability will allow us to assess kinetics and spatial distribution of reaction pathways of metabolites at low concentration with sub-second resolution. We have already demonstrated the fundamental physical principles: i.e. lifetime extension of NMR signals by long-lived spin states. This proposal transforms our advances into practical, general, and affordable technology which will give us unprecedented insights into the metabolic basis of brain function with clear potential for scanning broad patient populations.

Public health relevance
Project Narrative / Public Health Statement: The proposed research program aims to establish a powerful biomolecular sensing modality that outperforms existing biomolecular imaging methods in sensitivity to molecular transformations. The developed technology is very affordable and could enable any lab or even doctor’s office to conduct safe next-generation molecular brain imaging with immediate test results. This technology can be used for unprecedented metabolic mapping of brain function and as a broadly available diagnostic tool that will provide deep fundamental insights into neurological function in animals and humans during health and disease.